Advancing Breast Health in Uganda

PROJECT SUMMARY/ABSTRACT
Formative work the Breast Health Global Initiative (BHGI), in partnership with Ugandan stakeholders, identified
significant barriers to timely diagnosis and effective treatment of breast cancer for Ugandan women.
Stakeholders subsequently requested technical and scientific support from BHGI to develop breast health
guidelines appropriate to the Ugandan setting, in concert with an implementation plan to translate these
guidelines into practice. This application seeks funding for a one-year cooperative conference grant to hold a
Summit — Advancing Breast Health in Uganda— to be held in Kampala, Uganda in June 2022. Prior to the
Summit, preliminary work will focus on developing draft resource-appropriate evidence-based guidelines and
accompanying implementation strategies to improve breast healthcare, using existing resources developed by
BHGI over six Global Summits from 2002-2018. This work has already begun: BHGI, under the direction of the
Steering Committee, convened four Working Groups chaired by Ugandan multidisciplinary experts; held a
virtual meeting to launch the initiative; and formed four Scientific Advisory Committees (SACs). The four
Working Groups will focus on (1) Policy & Advocacy; (2) Primary Care & Referral Systems; (3) Diagnostic
Pathways; and (4) Treatment & Supportive Care. SACs will provide technical and scientific support.
Summit panelists and speakers for the Summit will be identified, and content developed by a Steering
Committee, based on feedback from Working Groups. The Summit is organized into 3 days: Day 1, Primary
Care & Referral Systems, and Policy & Advocacy; Day 2 Diagnostic Pathways and Treatment & Supportive
Care, and Day 3, Next steps for implementing guidelines in Uganda: Policy Requirements. Following
successful strategies in prior BHGI Summits, morning sessions will consist of moderated panel discussions;
afternoon sessions will consist of guided working sessions to synthesize evidence presented earlier each day
and produce finalized guidelines. Summit goals are: (1) bring together Ugandan and external experts
(population health scientists, clinicians, health economists and policy makers) to present and review draft
guidelines; (2) finalize guidelines and implementation plans including a roadmap to integrate these guidelines
into Uganda healthcare systems; (3) formalize a multi-stakeholder association The Ugandan Breast Health
Society. We will provide travel grants for trainees from Uganda, and for experts from other regions of sub-
Saharan Africa to attend. Post Summit activities include publication of Summit outcomes, and development of
dissemination strategies.

Public health relevance
PROJECT NARRATIVE At the request of Ugandan stakeholders, the Breast Health Global Initiative (BHGI) will provide scientific and technical support, and a forum for a multidisciplinary team of Ugandan health workers and researchers, and international experts, to develop guidelines to improve breast health outcomes for Ugandan women. Ugandan experts will review the state of the science and develop resource-appropriate and evidence-based implementation pathways and solutions to barriers in accessing breast healthcare across all levels of care in Uganda. Outcomes will be (1) published national breast health guidelines; (2) published peer-reviewed consensus statements; (3) plans to disseminate these guidelines to similar resource-settings.